Impairment of anti-Plasmodium T cell memory by type I Interferon Signaling

PROJECT SUMMARY AND ABSTRACT
Annually, liver disease accounts for nearly 2 million deaths worldwide. Immune responses in the liver must
balance elimination of local infection with non-reactivity to benign gut-derived dietary and microbial antigens.
Excessive/dysregulated immune activation in the absence of infection promotes liver tissue damage while
insufficient immunity facilitates the development of chronic infection and hepatocellular carcinoma. Thus, there
is an urgent need to pinpoint immunological pathways that can be modified to control hepatic maladies without
compromising liver function. Our proposal will utilize malaria liver stage infection as a model system to identify
factors that dictate the quality of hepatic CD8 T cell responses. Plasmodium malaria parasites initially infect the
liver and replicate as liver stages within hepatocytes to generate exoerythrocytic merozoites that are released to
infect red blood cells. Liver stages are essential to establish infection but are clinically silent and were only
recently shown to induce a significant innate immune response. We previously demonstrated that Plasmodium
infection induced IFN-I signaling weakens anti-Plasmodium adaptive immunity by promoting the development of
dysfunctional hepatic CD8 T cells. This dysfunctional signature bears striking similarity to the T cell exhaustion
program induced by chronic infection and tumors. Yet, how does a transient, non-chronic infection that is limited
to hepatocytes induce such profound T cell dysfunction? We now report that IFN-I signaling solely in hepatocytes
is a major contributor to the induction of hepatic CD8 T cell dysfunction suggesting that hepatocytes are central
immune platforms that determine the quality of adaptive immunity in the liver. From functional assays and gene
expression analyses of hepatocytes enriched from mice infected with rodent malaria parasites or human-liver
chimeric mice infected with Plasmodium falciparum, we show that this IFN-I response is initiated by hepatocyte
expression of the IRF3 transcription factor. Moreover, we establish that concurrent with IFN-I induction, LS
infection profoundly reshapes the hepatocyte transcriptome and metabolome likely inducing an
immunosuppressive microenvironment around the infected hepatocyte, which we predict impairs an ensuing
hepatic T cell response. In Aim 1, we will use cutting-edge single cell multi-omic studies and functional analyses
to identify hallmark features of Plasmodium infection induced CD8 T cell dysfunction to determine whether it is
distinct from bonafide T cell exhaustion. In Aim 2, we will focus on hepatocytes to characterize how parasite-
induced IFN-I signaling remodels intrahepatocyte transcriptomes and metabolomes to impair hepatic CD8 T cell
responses. In Aim 3, we will generate novel transgenic parasites that deliver viral antagonists of IRF3 into the
infected hepatocyte to compromise Plasmodium-induced IFN-I signaling solely within the infected hepatocyte
and improve anti-Plasmodium adaptive immunity. These aims will broaden and deepen our understanding of the
immune responses to a complex eukaryotic pathogen to improve liver-directed anti-malaria vaccines.

Public health relevance
PROJECT NARRATIVE We previously reported that type I interferon signaling induced in response to the asymptomatic liver stages of malaria parasite infection compromise protective adaptive immunity by inducing dysfunctional hepatic memory CD8 T cells. Using infection of the liver by malaria parasites as a model for hepatotropic infection, this application seeks to characterize malaria-induced hepatic CD8 T cell dysfunction to determine how hepatocyte-intrinsic type I interferon signaling reshapes hepatocyte transcriptomes and metabolomes to impair hepatic T cell immunity. Observations from this work will guide the development of highly efficacious liver directed anti-malaria vaccines.